Cholecystokinin receptors in lateralized vagal reward signaling

PROJECT SUMMARY
The vagus nerves transmit sensory information from the gastrointestinal tract to the brain, playing a crucial role
in the neural control of feeding and energy homeostasis. These signals are conveyed to brain systems that
regulate both the homeostatic control of feeding and the cognitive aspects of food reward. The gut-innervating
afferent fibers of the vagus nerve demonstrate lateralized activation of midbrain “reward” circuitry, with
projections through the right, but not the left, vagus nerve driving reward-related behaviors and dopamine
release. One key hormone involved in feeding regulation is cholecystokinin (CCK), a peptide released in the gut
in response to food intake. Acting through the vagus nerve, CCK signaling is traditionally known to promote
satiety, a physiological state in which feelings of fullness signal the cessation of eating. However, recent research
has shown that CCK also plays a critical role in the vagal signaling pathways that drive post-ingestive
macronutrient preference. The ability of vagal CCK signaling to reinforce food-seeking behaviors suggests that
it may play a role in vagally-mediated reinforcement. The central hypothesis of this proposal is that
asymmetrically expressed CCK receptor-expressing vagal neurons critically contribute to lateralized
interoceptive reward signaling. The goal of this project is to determine the extent to which these neurons
contribute to lateralized vagus-mediated reinforcement of appetitive behaviors. In Aim 1, we test the hypothesis
that right vagal neurons are more responsive to CCK than left vagal neurons. In Aim 2, we test the necessity of
right versus left CCK receptor-expressing vagus neurons in the development of fat preference. In Aim 3, we
determine the extent to which CCK receptor-expressing vagal neurons are required for the reinforcement of
learned behaviors by right vagus nerve stimulation (VNS). These experiments will reveal new insights into the
mechanisms underlying lateralized interoceptive reward signaling. In doing so, the proposed work will critically
inform the development and optimization of VNS and other therapeutic approaches for the treatment of obesity
and metabolic disorders.

Public health relevance
PROJECT NARRATIVE The vagus nerves play an essential role in transmitting information about the nutritional and rewarding properties of food from the gut to the brain, influencing feeding behavior and reward processing. The proposed research will test the mechanisms by which the right vagus nerve may reinforce food choices and appetitive behaviors through midbrain reward systems. These experiments will provide new insights into vagal gut-brain circuits that reinforce dietary preferences for energy-dense, high-fat foods, providing a foundation for the development of effective therapeutic strategies for addressing obesity and related metabolic disorders.